CATARACTOGENESIS BY LOW DOSES OF KEV NEUTRONS

Specific objective is to extend our previous studies of the Relative Biological Effect (RBE) of very low doses of neutrons down to lower neutron energies, of more relevance to radiation protection.